Methods for Isotope Labelling of Glycans

PROJECT SUMMARY. Glycomics studies are crucial for correlating changes in glycan structure and abundance
to the phenotype of a biological system. Among the available platforms to facilitate glycomics analyses, labelling
with stable isotopes has been implemented to decipher structural and quantitative aspects of carbohydrates in
healthy and diseased states. Isotopically labelled saccharides are also a useful tool for in vivo metabolic profiling
and in mechanistic studies in chemistry and enzymology. While some structures are commercially available, a
generally applicable and non-destructive method for introducing stable heavy isotopes either in simple
monosaccharides or complex oligosaccharides are not available. To overcome these limitations, we will develop
a chemical technology based on carbon-13 labelling. To achieve this objective, we will pursue two specific aims:
In Aim 1, we will optimize catalytic methods for selective labelling of monosaccharides with carbon-13. This
method will selectively exchange the anomeric position with a heavy isotope from readily available sources of
carbon-13. In Aim 2, we will apply isotope labelling method to three classes of saccharides of biomedical
relevance, namely heparan sulfate proteoglycans, N-linked glycoproteins, and human milk oligosaccharides. Per
requirements of PAR-19-254, we will benchmark the new technologies against the current state-of-the-art
methods for oligosaccharide quantification. Upon completion of this project, a new catalytic technology for
labelling of carbohydrates and glycoconjugates will be available and will complement the current tools for
quantitative glycomics. In a broader sense, integration of these novel chemistries with modern mass
spectrometry techniques will provide better tools for therapeutic diagnosis.

Public health relevance
PROJECT NARRATIVE. Carbohydrates play a critical role in mediating myriad physiological processes and are involved in various disease-related processes. Quantitative analysis of changes in carbohydrate structure and composition is therefore important to understand pathological process. This project seeks to overcome technical challenges of analyzing carbohydrate mixtures by developing chemical methodologies for isotope labelling. If successful, this new technology will facilitate analysis of carbohydrate composition in healthy and diseased states.